Electron Microscope Core Core Facilities for Analysis of Neural Circuit Structu

The Electron Microscopy Core enables neuroscientists to visualize neural circuit structure with nanometer resolution using traditional transmission electron microscopy and the high-throughput electron microscopy developed at Harvard for Connectomics. Like the Light Microscopy Core, the Electron Microscopy Core enables valuable neuroscience research and promotes a new model for interdisciplinary neuroscience, ultimately to address fundamental issues of human health.